Health Outcomes Predict dEmentia in Stroke (HOPES)

Project Summary/Abstract
The Center for the Study of Aphasia Recovery (C-STAR, P50-DC014664) explores recovery
and prognosis from language impairments post-stroke. We utilize various neuroimaging
techniques and behavioral assessments to identify factors associated with recovery. Recent
evidence from our group has shown that measures of health are indicators of prognosis, with
poorer health being associated with factors often implicated in dementia research (presence
of comorbidities, rate of exercise, and extent of small vessel disease). This proposal will
allow us to examine the relationship between modifiable (health) and unmodifiable (genetics,
stroke) risk factors in stroke aphasia to 1) predict mild cognitive impairment, 2) investigate
speech and language therapy gains, and 3) along with our neurotypical dataset (Aging Brain
Cohort; ABC), investigate factors associated with the rate of cognitive decline in stroke
aphasia vs typical aging. We will examine these questions using an existing database of
individuals with stroke aphasia (N=104) which includes patient demographics, stroke and
aphasia data, alongside our neurotypical database (N=96) which includes patient
demographic, genetic data, neural measures, health factors and behavior). Our planned
analyses will provide novel insights into the modifiable and unmodifiable risk factors for
developing cognitive decline following a stroke, and the interaction between cognitive decline
and speech and language therapy gains in stroke aphasia.

Public health relevance
Project Narrative This proposal will investigate how modifiable and unmodifiable risk factors contribute to cognitive decline in persons with stroke aphasia and neurotypical controls. Previous work has suggested that it is common to experience cognitive impairment following a stroke. We will extend this work by focusing on individuals with stroke aphasia and will examine the contributions of modifiable and unmodifiable risk factors (demographics, genetics, neural measures, and health) on cognitive impairment and speech and language therapy gains.